Title: Pharmacokinetic, pharmacodynamic , and toxicological interactions among Opioids and Cabotegravir

SUMMARY STATEMENT
We have identified a previously overlooked problem regarding a possible drug-drug interaction (DDI) among
patients with opioid use disorders (OUDs) with high risk to HIV that are using Pre-Existing Prophylaxis (PrEP).
Morphine and cabotegravir are metabolized by the enzyme, uridine diphosphate glucuronosyltransferase (UGT)
and when combined, can influence the rate of drug metabolism, creating a potential risk for toxicity in people
with comorbid HIV and OUD. Opioids are the cornerstone of pain management, and as long as they are
continuing to be widely prescribed for chronic pain and/ or illicitly abused, the opioid epidemic in the United
States (US) will continue to soar. OUDs are often comorbid with HIV infection, and studies have shown that
individuals who misuse opioid analgesics, as well as other illicit drugs, are most likely to have difficulty adhering
to antiretroviral (ART) medication regimens. Adverse DDI between ART and opioid abuse and/or medications to
treat OUDs are frequently reported. In a recent publication, we showed that co-exposure with morphine and ART
in HIV-infected brain reservoirs led to failure in the attenuation of viral load and increased secretion of viral-
induced inflammatory molecules. Co-exposure with morphine and ART caused an increase in several histone-
modifying enzymes which correlated with an increase in the mRNA expression of different variants of the μ-
opioid receptor; suggesting that changes in epigenetic and opioid receptors may be involved in the regulation of
DDI. Gap in Knowledge: Not much is known about the potential DDI among cabotegravir and morphine and/or
medications to treat opioid use disorders (naltrexone). On that note, we hypothesize that when taken in
combination, cabotegravir and morphine and/or naltrexone exhibit synergism that can influence the
pharmacokinetic (PK) and pharmacodynamic (PD) responses, resulting in drug toxicity. We further posit that
epigenetic variations due to the combined exposure of cabotegravir and opioids control the PK/PD responses
by regulating drug-metabolizing enzymes, transporters, and/or the μ-opioid receptors. The goal of this new
application is to evaluate potential interactions among opioids and cabotegravir. Specific Aim 1 will evaluate
the PK responses among the three groups of drugs (cabotegravir - morphine - naltrexone) in healthy mice model.
Specific Aim 2 will evaluate the PD responses, and toxicological interactions among the three groups of drugs
in non-infected or HIV-infected humanized mouse model. Specific Aim 3 will evaluate the PK/PD, and
toxicological interactions among the three groups of drugs in non-human primates. Impact: Findings will provide
novel insights in the potential mechanisms involved in the adverse DDIs among cabotegravir and opioids which
are used in clinical settings. Furthermore, an understanding of the pharmacoepigenetics will identify new targets
that might help in the interference with pharmacokinetics or pharmacodynamics of opioids and cabotegravir.

Public health relevance
PROJECT NARRATIVE The enclosed new application is in response to NOT-DA-20-013 and will evaluate the drug-drug interactions among opioid abuse (morphine), medications to treat opioid use disorders (naltrexone), and medications for HIV prevention (Cabotegravir). Pharmacokinetic, pharmacodynamic, and toxicological interactions among the three classes of pharmaceuticals will be studied using mouse models and non-human primate systems.